CONTROL OF T CELL SYNAPSE STABILIZATION AND SIGNALING

PROJECT SUMMARY
How do T cells find and their targets? Thanks to studies using high abundance, high affinity agonists and
antibodies, many of the signaling pathways downstream from TCR engagement – through lck, ZAP-70, LAT,
and further adapters and transcription factors – are described. Decades of structural analyses have also revealed
the critical residues for ligand binding. Yet, as we have attempted to make T cells more tuneable and use them
as cellular therapies, it is evident that we still cannot create a T cell that has all the features—sensitivity,
specificity, effector functions—that we want in order to achieve clinical efficacy.
Receptors reside on cell membranes. Cell membranes move and bend and provide 3D surfaces on which
receptors can transit, both individually and in patches. We hypothesize that the relationship of T cell receptors
to their underlying membrane is critical for determining their function.
This proposal will study the effect of the subsurface domain distribution of receptors, achieved through
engineering of T cells (Aim 1), engineering of surrogate ligands and cells (Aim 2) and through adoption of cell-
cell fusogens that alter the immediate sequellae of membrane-membrane apposition (Aim 3). In all cases, we
will be studying the output across a range of measures, starting by studying the 3D distribution of engineered
receptors over time, moving to studying the effect of the perturbation on activation measures, and finally
assessing these modification in models of human disease. The results of these studies will provide us with critical
information about the interacting nature of receptors and membranes as they influence T cell activation.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will determine how T cells are activated. T cells are the cells of the immune system that kill tumor cells and provide protection against viruses and bacteria. When T cells are mis-activated they can attack one’s own organs and cause autoimmunity. The results of our work will provide new ways to engineer T cells for better anti-tumor specificity as well as new ways to use drugs to counter over-activated or mis-activated T cells, thereby reducing inflammation and autoimmunity. This project supports the NIH’s mission and aligns with its high-priority effort to address critical current and future issues in public health.